Final - Development of Regioselective Alkene Dicarbofunctionalization Reactions

Project Summary/Abstract
Under the parent award, we are developing catalytic dicarbofunctionalization of unactivated alkenes, a powerful
method to create two carbon-carbon bonds in one step. Mechanistic investigations have been a research staple
for us to better understand and improve these catalytic reactions. One of the key strategies we implement in our
mechanistic studies is the analysis of reaction progress in real-time by in-situ 19F NMR spectroscopy. This
strategy allows us to identify reaction intermediates, and measure simultaneously the rates of formation of
desired products, regio-slipped products and undesired side products. We capitalize on this critical mechanistic
knowledge to understand the subtleties of a catalytic cycle and identify suitable reaction parameters to improve
and expand the scope of the reactions proposed in the parent grant. However, our progress in mechanistic
analysis has been seriously hampered by limitations on long-term NMR reservations and 24/7 access to a
dedicated NMR spectrometer in our NMR facility. We anticipate that the acquisition of the requested Oxford 60
MHz X-Pulse NMR spectrometer, capable of sampling multiple nuclei of interest to us (1H, 19F, 11B and 31P) at
variable temperature, will tremendously ease on our limitations, increase our research capacity to make
significant progress rapidly, and help fill in a significant knowledge gap in the field of alkene
dicarbofunctionalization reactions toward meeting the goals of the parent grant.

Public health relevance
Project Narrative The NMR spectrometer is a vital equipment to investigate the catalytic regioselective dicarbofunctionalization reactions of unactivated alkenes. We will use this equipment to elucidate reaction mechanisms via real-time in- situ kinetic analysis, reaction monitoring and identification of transient intermediates. These mechanistic studies will assist us in expanding the reaction scope to the synthesis of complex motifs relevant to pharmaceuticals, bioactive molecules and drug targets, which will have significant impacts on the biomedical mission of the NIH.